Nicotine and Tobacco Messaging on Youth-Oriented Social Media Platforms

Use of nicotine and tobacco products (NTPs) among youth is a persistent public health problem in the United States. Initiation of NTPs in adolescence is associated with increased frequency of use, adverse impacts on brain development, nicotine addiction, and increased risk of cancer. A major factor associated with NTP use is exposure to media advertisements for these products; this is particularly true for Black, Hispanic, and sexual minority (i.e., gay, lesbian, bisexual) youth. With the proliferation of social media, youth are now exposed to messaging from both tobacco company marketing and self-generated content from social media users. However, it is not well known how these youth are exposed to NTP-related misinformation (i.e., messages such as “vaping is much safer than cigarettes”) on social media and how these exposures are associated with susceptibility to NTP initiation. Therefore, the goal of this proposal is to first identify NTP-related misinformation on a variety of youth-oriented social media platforms and then assess associations between misinformation exposure and susceptibility to NTP initiation among youth, particularly youth who identify as Black, Hispanic, and/or gay, lesbian, or bisexual. Informed by these results, we will develop health communication messages to counteract misinformation and assess their acceptability to youth. Core to this proposal is the use of a Youth Participatory Action Research approach via the development of a Youth Collaborative (n=20). Comprised of youth ages 13-17, the Youth Collaborative will play an integral role in completing the following specific aims: (1) classify the most pervasive and salient NTP-related misinformation on youth-oriented social media platforms via human-centered design (HCD) activities, social media data collection, qualitative and automated data analysis processes, and social network analysis; (2) assess social media-based exposure to NTP-related misinformation and associations with susceptibility via a cross-sectional survey of with 700 youth ages 13-17 with oversampling of Black, Hispanic, and gay, lesbian, and bisexual youth; and (3) develop health communication messages using HCD activities and assess the acceptability of these messages with a subsample of youth from Aim 2 who are susceptible to NTP initiation. Our interdisciplinary team has collaborated for over a decade to examine youth attitudes and behaviors related to nicotine and tobacco products, social media use, engagement with media, and community-based participatory research. We will leverage this knowledge and experience to complete these aims, the results of which can be used to develop scalable interventions that can counteract targeted misinformation and prevent NTP initiation among youth and ultimately eliminate disparities in tobacco-related morbidity and mortality, including cancer, among these populations.

Public health relevance
This proposal will use young people as scientific partners to identify incorrect information about nicotine and tobacco (i.e., “vaping is much healthier than cigarettes”) on social media. In collaboration with these youth, we will then assess how interacting with these types of messages is associated with susceptibility—or being willing to try a nicotine or tobacco product—among youth ages 13-17, particularly Black, Hispanic, and sexual minority (i.e, gay, lesbian, bisexual) youth. This information will be used to develop messages to counteract incorrect information, and we will assess how acceptable the messages are to young people through surveys and interviews.